Functionalized Receptors for Efficient Epitope Recognition

PROJECT SUMMARY
Biomedical science relies heavily on methods for attaching ligand binding sites to proteins. Such epitope
tags are important for protein affinity purification, for improving protein solubility, and for adding
functionality to proteins such as fluorescent labels or sites for chemical modification. The proposed
research aims to develop synthetic receptors that target proteins engineered with efficient epitopes
comprising only 2-3 amino acid residues. The epitopes are bound site-selectively and with subnanomolar
affinity by small (1-2 kDa) monofunctional synthetic receptors with added ability to bind, fluoresce, or
attach to solid supports. The receptors are stable and functional in physiological conditions, including
serum, and proteins bound to these receptors can be released on demand upon the addition of small
molecule competitors. The proposed aims will: 1) further optimize the epitopes; 2) install the epitopes into
recombinant proteins and human insulin; and 3) develop monofunctional derivatives of the synthetic
receptor to enhance binding and to enable affinity purification and protein sensing. The proposed epitopes
will add function to target proteins while having minimal impact on structure and activity. The proposed
work builds on the rules for sequence-selective recognition of peptides and proteins by cucurbit[n]urils
established in the undergraduate research lab of the PI. Many research groups have developed applications
built on these rules, and we anticipate that the proposed research will establish a core competency that
should facilitate existing biomedical applications and inspire new ones.

Public health relevance
PROJECT NARRATIVE The proposed research will improve a core capability of the biomedical science community by enabling access to important proteins with minimal impact to their functions. This access improves our ability to more safely formulate protein drugs and to more accurately measure protein factors in medical tests.